Understanding Cochlear Amplification and Otoacoustic Emissions

Project Summary
Realizing the full potential of otoacoustic emissions (OAEs) as noninvasive probes of cochlear function
requires understanding the physical and physiological mechanisms that generate and shape these
sounds. To address important unresolved issues of cochlear mechanics while improving our
understanding of OAE generation, we propose three aims involving innovative theoretical modeling
rigorously tested by experimental measurements. The first Aim seeks to understand how the active,
nonlinear cochlea analyzes frequency sweeps, an ecologically important and readily manipulable class
of dynamic sounds. Through an innovative mix of behavior, physiology, and theoretical modeling we will
test our hypothesis that up-down differences in behavioral masking, cochlear suppression, and the
generation of reflection-source OAEs all share a similar, non-monotonic dependence on sweep rate and
direction, consistent with the involvement of temporal suppression. As an important control, we will
evaluate possible contributions from feedback-based auditory reflexes. We will interpret our results
using models of cochlear wave amplification and OAE generation to test the hypothesis that the
measured response patterns arise via mechanisms involving interactions between traveling-wave
dispersion and nonlinear suppression. The second Aim explores the micromechanics of cochlear wave
amplification and its consequences for the generation of distortion-product OAEs (DPOAEs). We study
DPOAE generation in tightly controlled models that incorporate a variable mix of both local (classical)
and nonlocal (push-pull) amplification, the latter as suggested by the prevailing interpretation of the
oblique geometry of the outer hair cells within the organ of Corti. The project will determine how the
known properties of DPOAEs constrain the nature of the active forces responsible for boosting the
sensitivity of hearing. The third Aim studies contributions to cochlear gain arising not directly via active
forces within the organ of Corti but via hydrodynamic effects (“pressure focusing”) that depend on fluid
coupling within the geometry of the cochlear duct. Our methods allow us to vary the hydrodynamic
coupling independent of cochlear micromechanics, enabling us to evaluate the robustness of a
promising new method for understanding the functional role of the many details of cytoarchitecture.
Completion of these Aims will significantly enhance our understanding of OAE generation and its
relationship to cochlear amplification and nonlinearity. The knowledge we gain is also directly relevant
to our long-term goal of improving the power of OAE-based diagnostics and other technological
applications—such as hearing aids and preprocessors for speech-recognition devices—that benefit
from the knowledge of cochlear amplification, nonlinearity, and signal processing.

Public health relevance
Project Narrative Our experiments and models address the mechanisms by which healthy ears amplify, analyze, and generate sound. Sounds from the ear, known as otoacoustic emissions (OAEs), are widely used for noninvasive tests of hearing function. By improving our understanding of cochlear amplification, nonlinearity, and the mechanisms of OAE generation, the proposed work lays the groundwork for boosting the power of clinical hearing tests and improving the design of auditory prosthetic devices.